STEROIDOGENESIS IN HYPERANDROGENISM

To clarify the role of adrenal and ovarian steroidogenesis in the pathophysiology of the phenotype associated with chronic anovulatory hyperandrogenism. In this protocol, ACTH and hCG stimulation tests are used to determine androgen production from the adrenal and ovary, respectively. Molecular genetic studies performed to determine if patients carry mutations in the genes encoding steroidogenic enzymes. These studies are the basis for phenotype/genotype correlations in chronic anovulatory hyperandrogenism. FSIVGTT are being added to obtain an insulin resistance phenotype. The otogeny of the increased LH/FSH ratio is being studied.